Career Enhancement Program

Project Summary
The primary objective of the Glioma SPORE Career Enhancement Program (CEP) is to attract talented
new investigators to translational glioma research. Potential CEP awardees include junior faculty beginning
their careers or established faculty members in other fields who wish to redirect their interests and efforts to
glioma research. We will maintain a comprehensive, system-wide process for solicitation of CEP
applications and an expert-based review process to select the most meritorious applicants. The CEP
program faculty consists of a multidisciplinary cohort of experienced, senior mentors for CEP awardees.
The CEP provides limited-duration funding for promising, junior translational investigators who are focused
on glioma research. The program will provide support, mentoring, and monitoring for CEP awardees. We
will maintain a monitoring process to measure progress and outcomes of CEP awardees and the CEP
program. We carefully monitor the progress of awardees through clearly enumerated metrics. The CEP is
assessed on an annual basis by the internal and external advisory boards. The CEP leverages institutional
resources to support and enhance the success of the program.

Public health relevance
Project Narrative The Career Enhancement Program provides research support for junior or new investigators in the field of glioma research. Through support, mentoring, and monitoring the program enables awardees to embark on successful careers in glioma research that will ultimately benefit patients.